Socioeconomic Status and Inflammation Across the Transition from Adolescence to Adulthood

Project Summary
Chronic inflammation has emerged as a potential pathway linking low-socioeconomic status (SES) with
disease risk; however, the development of SES disparities in inflammatory risk from adolescence to adulthood
is not well understood and there remains uncertainty over the underlying pathways. This transitional period
often involves normative changes in social relationships and sleep behavior. Given that psychosocial stress
and sleep disruption have both been implicated in inflammatory pathways, the transition from adolescence to
adulthood may be an ideal developmental period to assess SES associations with inflammation and elucidate
the psychosocial and biobehavioral factors that may underlie these associations. The present study will utilize
two independent datasets to assess SES links with inflammation at multiple levels, i.e., via circulating levels of
inflammatory markers and via gene expression of inflammatory pathways. The research will identify potential
psychosocial factors (i.e., social isolation, stress, discrimination) and biobehavioral factors (i.e., changes in
sleep duration and quality) that may explain how SES creates risk for a pro-inflammatory state.
Data from the first study were collected as a part of a longitudinal study of adolescent health and
experiences, in which N=350 youth were followed from the 10th/11th grade into 3-years post-high school.
Adolescents reported on psychosocial experiences, measured sleep via actigraphy for 8 nights, and provided
dried blood spot (DBS) samples to assess inflammation. Data from the second study will be collected from
N=150 young adults of diverse socioeconomic backgrounds at three time points throughout the first year of
college, in which participants report on psychosocial experiences during the transition to college, report on their
sleep duration and quality, and provide a DBS sample. The two datasets will be used to address three aims: 1)
investigate the relationship between SES and inflammation across the transition from adolescence to
adulthood, 2) identify psychosocial experiences that link SES with inflammation and 3) examine the role of
sleep in the association between SES and inflammation. It is hypothesized that low-SES will be significantly
associated with inflammatory risk, and that low-SES youth will show greater increases in inflammation over
time. Secondly, it is hypothesized that low-SES will be associated with adverse psychosocial experiences and
that these experiences will statistically mediate associations between SES and inflammation. Finally, it is
hypothesized that low-SES will be associated with poorer quality sleep, and that disruptions to sleep will
statistically mediate associations between SES and inflammation. Findings from this work will contribute to the
literature’s understanding of the biologic embedding of SES in health and can be used to inform interventions
aimed at reducing health risk for low-SES youth.

Public health relevance
Project Narrative Chronic inflammation has emerged as a biomarker of interest linking low socioeconomic status (SES) with disease risk; however, the development of socioeconomic differences in inflammation during adolescence and the biobehavioral and psychosocial underpinnings of the link are not well understood. The present study explores SES associations with markers of inflammation during a window of substantial psychological, biological, and social change—the transition from adolescence to adulthood—with the goal of identifying factors that may explain how SES influences risk for inflammation. Findings from this research can provide foundational knowledge on the development of socioeconomic disparities in health and identify potential routes for intervention (e.g., improving sleep and social connection) to reduce health risk for youth of low socioeconomic backgrounds, supporting NICHD’s mission to enhance the lives and wellbeing of adolescents.